Engineering novel CAR-T cell therapy to overcome the cancer cell glycocalyx

Project Summary
The cancer cell glycocalyx provides a major line of defense against detection and destruction by surveilling
immune cells. By acting as a steric material barrier, the cancer cell glycocalyx can disrupt the close, intimate
contact required for target engagement by effector immune cells. Cancer-associated cell-surface glycoproteins
or glycans are highly upregulated in most breast cancer cells and glioblastoma. With the rapid advancement of
immunotherapies and adoptive cell therapies for cancer, new strategies to disrupt or penetrate the glycocalyx
barrier are needed for improved cancer immunotherapy, particularly for solid tumors. We recently found that
cancer-associated mucins form a nanoscale shield, and even a 10-nanometer change in the glycocalyx thickness
can significantly affect immune cell-mediated cytotoxicity. The long-term goal is to develop safe, effective CAR-
T therapies for solid tumors. Thus, the overarching goal of this proposal is to develop new strategies to endow
CAR-T cells that can bind to or penetrate the cancer-associated glycocalyx barrier in solid tumors. To attain the
overall objective, we will pursue two specific aims: (1) Engineer CAR-T cells to strengthen the immune synapse
by enhancing binding to the cancer cell glycocalyx and (2) Develop CAR-T cells that break through the cancer
cell glycocalyx using cell-surface glycocalyx-editing (GE) enzymes and small-molecule inhibitors. In Aim 1, we
will enhance CAR-T binding using two strategies: (i) Glyco-Bridge, an antigen receptor without an intracellular
domain, and (ii) a leucine zipper-fused scFv approach (Zip-scFv). We hypothesize that Glyco-Bridge or Zip-scFv,
will improve CAR-T activity by strengthening the immune synapse. In Aim 2, we will engineer CAR-T cells to
express glycocalyx-editing enzymes on their membrane (GE-CART) to penetrate the barrier. We will also explore
small-molecule inhibitors to reduce glycocalyx thickness and their synergy with CAR-T therapy. We hypothesize
that GE enzymes or small-molecule inhibitors will reduce the glycocalyx, exposing tumor epitopes for more
effective CAR-T recognition. These strategies aim to improve CAR-T therapy for solid tumors like breast cancer
and glioblastoma by overcoming the glycocalyx barrier. To complete the aims, I have outlined a five-year career
development plan that includes coursework, conferences, seminars, and structured mentoring in experimental
design, glycomics, mouse modeling, CAR-T signaling, and clinical oncology. This plan is designed to acquire
the necessary skills to perform my research and achieve my goal of becoming an independent investigator in
both basic and translational research. This research is directly relevant to the mission of the NCI to conduct
cancer research to advance scientific knowledge and help all people live longer healthier lives using immune cell
therapies. Under the mentorship of Dr. Marcela Maus, a worldwide leader in cellular immunotherapy, I will
conduct this research at Massachusetts General Hospital and benefit from the exceptional research and teaching
environments provided by my scientific advisory committee, which includes Dana-Farber Cancer Institute, Beth
Israel Deaconess Medical Center, Boston Children’s Hospital, and Massachusetts Institute of Technology.

Public health relevance
Project Narrative Cancer cells encase themselves in a soft material coating, termed the cellular glycocalyx, with specific properties that protect them from recognition and destruction by the immune system, including engineered CAR-T cell therapy. This research project aims to develop new strategies to equip CAR-T cells to effectively bind to or penetrate the cancer-associated glycocalyx barrier in solid tumors. These strategies are expected to advance CAR-T therapy for solid tumors by addressing a key mechanism of immune evasion.